Development of a Novel, Targeted Small Molecule Inhibitor of the Nucleotide Salvage Pathway to Treat Underserved Tumor Types

PROJECT SUMMARY
Trethera, a clinical stage biopharmaceutical company, has developed a small molecule drug, TRE-515, to target
the nucleoside salvage pathway via a key rate-limiting enzyme, deoxycytidine kinase (dCK). We have shown
that dCK is expressed at high levels in a variety of solid tumors, and TRE-515 selectively targets cancer cells
based on their high expression of, and dependence on, dCK. Notably, TRE-515 is the only salvage pathway
inhibitor currently in clinical development, and no salvage pathway inhibitors are approved as cancer
therapeutics. Currently, Trethera is evaluating TRE-515 in a phase 1a open-label, dose escalation study in
patients with solid tumors (IND #131939). Acceptable safety and tolerability have been demonstrated across
three TRE-515 doses (40mg, 80mg, 160mg) in 10 patients. Preliminary pharmacokinetic (PK) data indicate an
acceptable half-life, rapid absorption, and low variability among patients, and early and pharmacodynamic (PD)
data demonstrate effective target inhibition. Notably, early signs of anti-tumor activity have been noted, with 50%
of patients in the lowest dose cohorts showing stable disease. Our goal here is to perform a Phase 1 dose
expansion trial deploying a quantitative LC/MS based assay to determine serum
deoxycytidine (dC)/
deoxyuridine
(dU) levels and a novel PET imaging approach as complementary biomarkers to monitor drug activity and assess
preliminary antitumor activity. Whole-body dCK activity regulates the levels of serum dC and its metabolite dU,
and reductions in dCK activity via TRE-515 inhibition can be routinely monitored by measuring changes in plasma
dC/dU using an LC-MS assay we developed. [18F]CFA is a PET radiotracer that can be used to non-invasively
measure dCK activity in tumors (IND #133911). As accepted by the FDA, male and female patients (N=12) with
advanced refractory solid tumors will be administered 320 mg TRE-515 as a once daily oral dose. The LC/MS
based assay to measure serum dC/dU levels will be further developed and used as an easily accessible
biomarker to assess patient response to TRE-515 (Aim 1). Biomarker studies using the recently invented, IND-
accepted positron emission tomography (PET) probe, [18F]Clofarabine ([18F]CFA), will be used for in vivo
monitoring of the effects of TRE-515 on dCK activity (Aim 2). Safety assessments, biomarker studies, and
Response Evaluation Criteria in Solid Tumors (RECIST) will be used to assess tumor responses in patients. Trial
milestones include i) >1.5X increases in serum levels of dC + dU after initiating TRE-515 therapy, reflecting drug
target inhibition and ii) greater than 33% reduction in [18F]CFA tumor uptake following TRE-515 treatment.
Success in the proposed trial will support future Phase 1 and 2 clinical trials to determine efficacy, safety,
combinations, patient selection, and optimal dose regimen of TRE-515.

Public health relevance
PROJECT NARRATIVE With cancer as the second leading cause of death in the US, there remains a pressing unmet need for new, more effective cancer therapeutics. Trethera has developed a small molecule drug, TRE-515, that inhibits deoxycytidine kinase (dCK), a rate limiting enzyme in the salvage pathway of nucleotide biosynthesis. Cancer cells utilize the salvage pathway to support rapid proliferation. TRE-515 holds an open IND and has been piloted in a dose escalation trial to establish preliminary dose, safety, and tolerability. The proposed Phase 1 dose expansion clinical trial will deploy a plasma deoxycytidine (dC) assay and a novel PET probe dCK imaging approach as complementary biomarkers to monitor drug activity and assess preliminary antitumor activity.